Towards precision risk stratification, diagnosis, and treatment: statistical and computational machinery for synthesizing information across massive, diverse sources of genomic and clinical data

Abstract/Project Summary
Biobanks, electronic health records, and clinical registries have collectively amassed a massive
amount of data on people’s genetic makeups and their clinical trajectories. Information in these
data sources, if properly synthesized, provides us an opportunity to identify treatments precisely
tailored toward individual patient profiles. However, heterogeneity across sites in patient
populations, data encoding procedures, and clinical practices pose significant statistical
challenges, compounded by computational challenges these massive data pose. We will meet
these statistical challenges by combining Bayesian hierarchical models, biomedical ontological
systems, and high-dimensional transfer learning methods: these tools will allow us to bring
together the larger amount of data from diverse sources to investigate biomedical questions
beyond the scope of any single source. We will scale the developed statistical framework to
sizes of modern genetic and clinical data by combining state-of-the-art computational algorithms
with hardware optimization techniques, including use of graphical processing units. We will
deliver the end products as open-source software packages for deployment in research and
clinical settings. We will demonstrate the proposed statistical and computational innovations
through direct applications to: genetic risk predictions for under-represented populations and
subgroup effect estimation for comparative effectiveness studies of type-2 diabetes treatments
using a federated network of healthcare databases. The machinery is more broadly applicable,
however; it for example allows integrating insights across data sources that provide different but
functionally-related metabolites and/or proteins. The proposed development thus constitutes an
important step towards extracting more scientific insights on disease mechanisms and effective
treatment strategies by synthesizing information across heterogeneous data sources.

Public health relevance
Project Narrative Due to the enormous variation in treatment pathways and in individuals’ responses, identifying right treatments for right individuals remains a serious challenge and requires synthesizing clinical insights across diverse data sources. Such synthesis of information has been hampered, however, by the heterogeneity in what types of data are collected and how they are represented in each data source. This project develops a novel statistical machinery to overcome this obstacle and scales it up to modern big data to help realize the promises of precision medicine.